STRUCTURE AND FUNCTION OF ADENOVIRUS DNA

Among objectives of these studies has been the application of physical, biochemical and biological techniques to characterize the structure and function of certain sequences (e.g., the inverted terminal repeats) and genes of adenovirus (Ad) DNA. In earlier studies, we first identified and characterized the VA RNA gene/transcript and inverted terminal repeats in Ad DNA. We have continued to investigate the specific functions of several early Ad genes, e.g., the VA and DNA-binding protein genes. Our results indicate that these latter genes are involved in the regulation of translation of certain viral mRNAs. Among methods used are gel electrophoresis, gene cloning, mutagenesis, base sequence analysis, and DNA transfection.